Tennessee State University Needs Assessment and Five Pillar Strategic Action Plan

Project Summary
Tennessee State University, has a unique profile as a Historically Black College and
University and urban land-grant institution. To that end, capacity and capabilities of research
administration, professional development, and physical research infrastructure to support
biomedical sciences and behavioral research at Tennessee State University has not kept pace
establishing our institution as a low research active (LRA) resource limited institution. Evaluative
assessment of the capacity and capabilities of such a heterogeneous ecosystem to monitor and
improve efficiency and effectiveness is essential. However, evaluative assessment approaches
and methodologies have lacked systematic study to improve research infrastructure, processes,
and productivity. Therefore, the proposed project will employ needs assessments to inform a
novel five pillar action strategy plan to enhance the capacity and capabilities of the biomedical
sciences and behavioral research ecosystem at Tennessee State University.

Public health relevance
Project Narrative Assessment needs of research administrative support and services and physical infrastructure that inform action plans have not been appropriately investigated and are essential to the NIH mission for disease prevention, treatment, cures.